Off target mechanisms of kinase inhibitor toxicities

ABSTRACT
Protein kinases orchestrate signal transduction pathways that are essential for most normal cellular functions.
Importantly, dysregulation of protein kinase signaling is both a cause and consequence of several human
diseases, especially cancer. Due to their druggability, more than seventy small-molecule therapeutics that
block the ATP-binding site of kinases have been approved, mostly for oncological diseases. Since the ATP-
binding site is relatively conserved, most targeted therapeutics can simultaneously inhibit on- as well as off-
target kinases, impacting efficacy as well as toxicity. Remarkably, chemical proteomic profiling has now
revealed that along with off-target kinases, protein kinase inhibitors can also bind and inhibit non-kinase
proteins. Particularly, the mitochondria-localized heme biosynthesis enzyme, ferrochelatase (FECH) has
emerged as a common target which can be inhibited by more than 10% of kinase inhibitors. How FECH
inhibition influences drug responses, especially toxicities, nevertheless remains unknown. Given their
widespread clinical use, there is a clear unmet need to understand the mechanistic basis of kinase inhibitor
toxicities, especially related to inhibition of non-kinase proteins. In this regard, our recent study has provided
the first evidence that off-target FECH inhibition by BRAF-kinase inhibitor vemurafenib contributes to renal
tubular epithelial cell (RTEC) death in vitro and nephrotoxicity in vivo. However, there is a knowledge gap in
our understanding of how kinase inhibitors are transported into normal cells, how the subsequent FECH
inhibition drives mitochondrial dysfunction, and how these pathways are differentially regulated in males versus
females. To address these questions, we have performed genome-wide RNAi and CRISPR based screens,
which have provided two key insights: (i) we have identified putative mechanisms responsible for vemurafenib
uptake, FECH inhibition, mitochondrial dysfunction, and RTEC cell death. (ii) We have uncovered a unique
gender-specific difference in toxicity, wherein vemurafenib treatment induces a female specific FECH
upregulation in RTECs imparting resistance to nephrotoxicity. In the current application we propose to utilize a
suite of in vitro and in vivo chemical genetic and gene knockout approaches to further illuminate the regulatory
mechanisms that govern toxicities associated with vemurafenib-induced FECH inhibition. Using this approach,
in Aim 1 we will employ RTEC-specific conditional knockout mice, primary cells, and CRISPR-based knockout
cell lines to examine the role of cubilin-dependent endocytosis in vemurafenib uptake, FECH inhibition, and
mitochondrial dysfunction. In Aim 2 we will utilize conditional knockout mice and primary cells to examine the
role of RUNX1 in female specific FECH upregulation and resistance to vemurafenib nephrotoxicity. These
studies are expected to provide broad insights into the pharmacological action of kinase inhibitors in normal
tissues including cellular uptake, non-kinase target inhibition, mitochondrial dysfunction, and transcriptional
mechanisms underlying gender differences in toxicities.

Public health relevance
NARRATIVE Protein kinase inhibitors are prominent components in the treatment of cancer and inflammatory diseases. Using unbiased functional genomic screening and unique genetic mouse models, we have found that kinase inhibitor mediated off-target inhibition of heme biosynthesis enzyme ferrochelatase contributes to toxicity in normal tissues. Our proposed studies aim to elucidate the molecular mechanisms that drive kinase inhibitor linked toxicities and could result in identification of potential mitigating strategies, which has high translational significance.